Redox Properties and Partners of the Yeast Thioredoxin Reductase Trr1

Project Summary.
Reactive oxygen species produced during the innate immune response slow pathogen growth and potentially
contribute to pathogen killing. However, pathogenic microbes counter this oxidative burst by using numerous
oxidant defense enzymes that detoxify reactive oxygen species, often by forming disulfide bonds. The enzyme
thioredoxin and its partner protein thioredoxin reductase ensure appropriate disulfide bond reduction in these
oxidized proteins, carrying out coupled reactions that are ultimately dependent on the reductant NADPH. While
thioredoxin is highly conserved across biological domains, the thioredoxin reductase in bacteria and unicellular
eukaryotes differs significantly on a structural and mechanistic level from its counterpart found in mammals,
making it a potential antimicrobial target. The microbial thioredoxin reductase is dimeric and employs a
conserved pair of cysteine residues in its active site that enable its interaction with and reduction of oxidized
thioredoxin. In addition, another cysteine, located near the C-terminus of the protein and positioned directly
across from the active site in the other subunit of the dimer, is subject to modification by thiol-modifying oxidants
in vitro and a thiol-reactive electrophile that commonly targets redox-active cysteines in vivo. Notably, this C-
terminal cysteine is conserved in fungal and Gram-negative bacteria but is less highly conserved in Gram-
positive bacteria. Because yeast lacking the cytosolic thioredoxin reductase grow more slowly than yeast lacking
the corresponding thioredoxins (which themselves have decreased growth rates), we propose that thioredoxin
reductase may partner with other proteins beside thioredoxin, perhaps through involving this conserved C-
terminal cysteine as an alternate site of disulfide exchange. In this proposal, we aim to (1) characterize which
cysteine residues in thioredoxin reductase are redox-active and how they contribute to its cellular function, and
(2) determine whether additional proteins besides thioredoxin partner with thioredoxin reductase. To accomplish
the proposed work, undergraduate students and I will use a combination of protein biochemistry and cell biology,
the latter being performed in baker’s yeast. Funding of this project will lead to a better understanding of the
fundamental biochemistry of thioredoxin reductase and may provide a new therapeutic avenue (or avenues) for
treating microbial infections by exploiting the unique features of the microbial protein. The award will also provide
meaningful opportunities for undergraduate students who have a long-term interest in biomedical research and
health-related disciplines.

Public health relevance
Project Narrative. Pathogenic microbes evade killing by immune cells, in part, by expressing a suite of virulence factors that protect against reactive oxygen species. The enzyme thioredoxin reductase plays a key role in this process by reactivating its partner protein thioredoxin, a key oxidant defense enzyme involved in microbial virulence, and other potential redox partners. In this proposal, we seek to uncover new aspects of how thioredoxin reductase works collaboratively with thioredoxin and these other proteins, offering insights into the function of this multiprotein system in homeostasis and oxidative stress.